Developmental Funds

Developmental funds have played a key role in facilitating scientific growth and increased interdisciplinary collaboration at Massey Cancer Center during the current funding period. As the Center will remain on a steep growth curve during the next 5 years, the specific goals to be pursued using developmental funds will be the following. [unreadable] Facilitation of strategic expansion of scientific programs through new faculty recruitment, [unreadable] Fostering new intra-programmatic and inter-programmatic scientific collaborations and pursuit of novel hypotheses by bringing together investigators to collaborate on innovative pilot projects, and [unreadable] Development of new shared resources to promote and expand high priority scientific activities of the Cancer Center.